Iowa Department of Inspection & Appeals RRT Maintenance

Enhancement of the multidisciplinary team coordination in foodborne outbreak investigations
and other food incidents are essential to the changing environment of public safety. Continuing
this endeavor is absolutely essential to meet the needs of Iowans in a timely and effective
manner.
The Bureau anticipates participation in this cooperative agreement will result in significant
enhancements in the quality of outbreak response, environmental assessments, and timeliness
of investigations. This will be obtained by the following:
• The State will sustain full conformance with the Rapid Response Team;
• The State has and will continue to actively engage through an annual face-to-face
meeting and participation in committees supporting RRT;
• The State has and will collaboratively develop strategies and share those strategies with
other states; and
• The State will provide FDA the foundation for pursuing regulatory action based upon the
finding of State Rapid Response Team.
The goal of this project is to sustain full conformance and continue being the responsive agent
for outbreaks and complaints. Continued support with this cooperative agreement will allow the
Iowa RRT program the resources to be responsive to Iowans.

Public health relevance
The Iowa RRT continue and expand an all-hazards food and feed protection program in collaboration with other RRTs and the FDA. The mission of the Iowa RRT is to effectively respond to foodborne outbreaks and identify potential preventive practices to protect the food supply and consumer health nationally and globally.